Real-Time Monitoring of Relapse in Eating Disorders

Project Summary/Abstract
Eating disorders (EDs) are severe mental illnesses with high mortality,1 few effective treatments,2–4 and
high relapse rates.5 Current evidence-based treatments for EDs often result in only 50% of individuals reaching
full remission of their symptoms.4 Further, even among those who do recover, many relapse. Up to 50% of
those who recover experience a relapse after treatment, about 25% of individuals go on to experience a
severe and persistent course of illness.5–13 Despite these high rates of relapse, the past decades of research
have culminated in very little improvement to prevent relapse within the EDs. To date, we still know very little
about why relapse occurs; in part, because ED relapse has been studied primarily as an outcome (i.e.,
relapsed or not) rather than a dynamic process can be intervened upon.9,14 Reconceptualizing and studying
ED relapse as a dynamic process will aid the identification of mechanisms of relapse and inform the
development and refinement of interventions and relapse prevention efforts. A well-established model of
relapse in substance use disorders (i.e., the cognitive behavioral relapse model; CBRM)15 can inform the initial
formation of a similar model in EDs. With research design informed by the CBRM, the proposed study will use
micro-longitudinal (i.e., ecological momentary assessment) and longitudinal (i.e., 3-month follow-up) methods
to capture lapses and relapse among those with EDs. The use of theory-driven, fine-grained assessment will
move the field toward the elucidation of distal and proximal mechanisms of relapse as it unfolds in real-time.
First, we will capture the presence and dynamics of lapses (i.e., momentary engagement in ED behaviors), and
whether features of lapses (e.g., frequency, time between lapses) predict eventual relapse (Aim 1). The CBRM
specifies that both tonic processes (i.e., stable, chronic factors) and phasic responses (i.e., immediate
precipitants) increase the risk for relapse. As such, we will test the associations between tonic processes and
the propensity for lapsing (i.e., higher urge valence and stability and lower urge variability; Aim 2). Additionally,
we will use generalized estimating equation models to examine whether each proposed phasic response (e.g.,
affect, emotion regulation skill use) predicts a lapse at the next survey (Aim 3). Lastly, the CBRM posits that
“high-risk” situations increase the likelihood of an individual lapsing. This study will aid in the initial identification
of said high-risk situations in EDs by using mixed-method (i.e., qualitative and quantitative) analyses to explore
contextual factors contributing to individuals’ reported lapses (Exploratory Aim 4). Overall, the proposed
project will implement advanced statistics and micro- and macro-longitudinal design to provide an
initial mechanistic understanding of relapse as it occurs in the EDs. Findings from this study will
inform the refinement of relapse prevention interventions and just-in-time adaptive interventions, and
ultimately, promote lasting, long-term recovery for those with this impairing and persistent disorder.

Public health relevance
Project Narrative Eating disorders are an impairing and deadly psychiatric disorder with high rates of relapse. There is a need to improve our understanding of relapse to inform the design of more efficacious treatments and relapse prevention efforts; however, current research is limited by examining relapse as an outcome longitudinally (i.e., across 1 year) rather than a process that unfold through moment-to-moment choices engagement in ED behavior (i.e., lapses). The current study – informed by existing theory of relapse borrowed from substance use disorders15 – will capture the process at the momentary level, with the ultimate goal of identifying mechanisms of relapse that can be addressed through existing and new treatments.